Hexosamine biosynthesis pathway metabolism during cardiac hypertrophy

PROJECT SUMMARY
A broad range of diseases, from hypertension to structural heart diseases like aortic stenosis or coarctation of
the aorta, cause pressure overload stress on the heart. In response, the heart undergoes hypertrophy (called
pressure overload hypertrophy or POH) which can promote adaptation or cause heart failure. Understanding
the mechanism underlying these opposite clinical outcomes would create new therapeutic opportunities. The
unstressed heart relies mainly on fatty acids for fuel but alters energy sources depending on availability. POH
causes the heart to increase its reliance on glucose for energy, but, unfortunately, this metabolic inflexibility
impacts hypertrophic growth and ventricular dysfunction. Therefore, improving the balance of sources used for
fuel generation during POH could promote adaptation but therapies targeting this approach have not been
realized partially because the mechanisms underlying these metabolic changes are incompletely known. Our
preliminary results identified a new mechanism potentially impacting substrate preferences for energy
production in the citric acid cycle during POH that we pursue in this proposal. Posttranslational modifications
by O-linked β-N-acetylglucosamine (O-GlcNAc) globally increase in hypertrophied hearts in humans and
animals. A widely accepted dogma assumes that the hexosamine biosynthesis pathway (HBP) leading to the
O-GlcNAcylation of proteins depends on metabolic changes, especially in glycolytic flux. However, our recent
data suggests the reverse; that HBP flux and O-GlcNAc levels determine cardiac fuel utilization. We recently
performed the most comprehensive evaluation of protein O-GlcNAc changes during POH and preliminarily
identified increased O-GlcNAc levels on multiple enzymes for fatty acids and glucose metabolism. Accordingly,
we propose a new paradigm that HBP flux and O-GlcNAc are key regulators of fuel preferences for the citric
acid cycle during POH. Thus, O-GlcNAc could potentially be targeted to treat metabolic inflexibility and prevent
cardiac maladaptation during POH. We test our new paradigm with three specific aims: 1) using transgenic
mice, we will evaluate the effect of modifying O-GlcNAc levels on left ventricular function and remodeling in
POH, 2) we will determine the effect of modifying O-GlcNAc levels on fatty acid oxidation, glucose oxidation
and glycolysis during POH, 3) we will determine the regulation of HBP flux and O-GlcNAc levels during POH.
Our project provides essential insights into the regulation of fuel sources during POH, along with determining
the effects of increased O-GlcNAc levels during POH. This knowledge could help develop of new therapeutic
approaches to prevent or treat the common clinical problem heart failure from POH. This project addresses key
knowledge deficits on the regulation of HBP flux and protein O-GlcNAc during hypertrophy, as well as their
functional effects during hypertrophy. They will, therefore, provide essential insights on targeting these
mechanisms for preventing or treating heart failure.

Public health relevance
PROJECT NARRATIVE Cardiac hypertrophy occurs from cardiovascular diseases and can lead to heart failure, disability, and death. This project will determine how a coordinated modification on multiple proteins during physiological stress affects heart function. The successful completion of this project will provide new information into the causes of heart failure that can be developed into new therapies.